Translational development and clinical evaluation of a bioengineered human lung graft for clinical transplantation

PROJECT ABSTRACT
Xylyx Bio, in collaboration with leading lung transplant physician-scientists at Vanderbilt University Medical Center
(VUMC), is advancing the development of Inspirex® Lung – a bioengineered human lung graft – to address the critical
shortage of donor lungs for transplant. This SBIR Direct-to-Phase II project aims to obtain Investigational New Drug
(IND)-enabling safety and efficacy data for Inspirex® Lung, including first-in-human transplantation studies. The project
builds on significant prior scientific achievements with our patented Xenogeneic Cross-circulation (XC) Platform and
demonstrated feasibility to bioengineer lung grafts from damaged/discarded human donor lungs using a porcine
bioreactor. We have demonstrated the ability to generate transplantable bioengineered lung grafts from discarded
human donor lungs, and shown robust graft function despite presence of residual porcine immune components. The
U.S. faces a dire shortage of donor lungs, with over 400,000 patients annually dying from end-stage lung disease,
and only 1 in 5 donor lungs meeting transplant criteria. Current approaches to increase the availability of lungs for
transplant include ex vivo lung perfusion (EVLP) devices, decellularized/recellularized lung scaffolds, 3D bioprinted
lungs, and xenotransplantation of pig lungs into humans; however, none of these approaches have shown significant
clinical impact on the number of lung transplants. Using swine in a novel role as a ‘bioreactor’ to bioengineer human
lungs, Xylyx aims to double the utilization rate of donor lungs, potentially eliminating waitlist deaths and significantly
expanding patient access to lung transplantation. The proposed research is organized into three specific aims: (1)
Assess clinical quality and safety of bioengineered lung grafts in preparation for human use, including immune
responses, pathogen surveillance, and graft health; (2) Establish specifications of the XC porcine bioreactor to support
optimal lung graft bioengineering, including minimizing residual porcine cells and cross-species immune responses
using pharmacologic, mechanical, and genetic approaches; (3) Evaluate safety and efficacy of bioengineered lung
grafts after first-in-human clinical transplantation. Expected outcomes include comprehensive graft quality and safety
assessments, with successful clinical transplantation as a project milestone and major value inflection point. Xylyx
has made significant progress toward commercialization, securing intellectual property and a worldwide exclusive
license, establishing a strategic partnership with VUMC and other transplant centers, and engaging key stakeholders
(regulatory, reimbursement, surgeons, patients/advocates, bioethicists, public relations, et al.). Xylyx is poised to lead
the clinical translation of this groundbreaking technology, with the goal of submitting an IND application, sponsoring
additional clinical trials, and ultimately marketing Inspirex® Lung grafts as a breakthrough life-saving treatment for
patients in need of new lungs. With a $5.5 billion U.S. organ transplant market, projected to grow to $11.2 billion by
2032, Inspirex® Lung has the potential to transform the field of lung transplantation and improve outcomes for patients
with chronic lung disease.

Public health relevance
NARRATIVE In this SBIR Direct-to-Phase II project, Xylyx proposes to address the critical shortage of donor lungs available for transplant by developing Inspirex® Lung, a bioengineered human lung graft generated using novel technology that rehabilitates damaged and discarded human donor lungs with the help of a medical-grade pig. By leveraging this breakthrough approach, we can significantly increase the number of available lungs for transplant, potentially saving thousands of lives each year. We will evaluate the safety and efficacy of our bioengineered lung grafts in human patients, with the goal of delivering a new life-saving treatment to patients suffering from chronic lung disease.